A method for preparing unbiased miRNA sequencing libraries (miR-ACS)

ABSTRACT This proposal addresses the problem of sequence bias in next-generation sequencing (NGS) of small RNAs such as microRNAs (miRNAs) as well as fragments of larger RNAs. Because dysregulation of miRNA expression has been implicated in cancer and other diseases, accurate expression profiling of all miRNA sequences is important for understanding miRNA biology and for development of new biomarkers and therapeutic targets. NGS is currently the most comprehensive approach for discovery and expression profiling of small RNA sequences. However, NGS expression profiling data underestimate the abundance of most miRNAs in a sample, some by as much as 10,000-fold. Knowledge of the true abundances in samples, and not just the relative changes between samples, is important for reliable identification of miRNAs as biomarkers or drug-target candidates. Other advantages of unbiased detection include the ability to discover novel RNAs and detect low-abundance RNAs that cannot be detected by current NGS methods, especially in samples with a low concentration of RNA. The source of bias in currently available methods of preparation RNA sequencing libraries for NGS is inefficient and sequence-dependent ligation of the two sequencing adapters to the sample RNAs. The major factors contributing to this ligation bias are intramolecular folding of the miRNAs and intermolecular folding between miRNAs and adapters, which affect the ability of the ligase to access and ligate the miRNA ends. Thus there is a need for new, more accurate methods, and most previous small RNA profiling experiments should be re-evaluated. To address these problems, we are developing a new approach, miR- ACS (miRNA-Adapter Circularization and Sequencing), for preparing unbiased sequencing libraries that is applicable to miRNAs and other small RNAs as well as small fragments of large RNAs used in general RNA- Seq. Key features of miR-ACS include (i) ligation of miRNAs with only a single combo adapter (CAD) that combines sequences of the standard 3'- and 5'-adapters used for Illumina sequencing, producing miRNA-CAD ligation products; (ii) circularization of the miRNA-CAD products; (iii) blocking of free CAD species that are not ligated to miRNAs; and (iv) RT-PCR amplification of the circular miRNA-CAD products to produce standard sequencing amplicons containing a single RNA-specific sequence insert flanked by the 5'- and 3'-adapter sequences. In Phase I, we have demonstrated the feasibility of the miR-ACS approach (proof-of-concept) by greatly reducing the miRNA sequencing bias in comparison to the best current library prep methods. In Phase II we will thoroughly optimize miR-ACS to maximize bias reduction and to allow sequencing of a larger variety of RNAs (up to 150 nt in size) with very low RNA inputs. In addition, we will streamline the protocol to facilitate its adoption by users and for commercial viability.

Public health relevance
HEALTH RELATEDNESS NARRATIVE MicroRNAs (miRNAs) are promising candidates as biomarkers of cancer and other diseases that could allow early diagnosis, sub-typing, choice of targeted treatments, and monitoring of the progress of therapy. Although, next-generation sequencing (NGS) is the method of choice for discovering and expression profiling of miRNAs, it underestimates the abundance of most miRNAs, some by as much as 10,000-fold because of sequence bias. The goal of this grant application is to eliminate this bias to allow discovery of new RNA species and determination of the true abundance of RNAs in biological samples.